CE25-029 - An examination of a state paid family leave policy as a family violence prevention strategy

PROJECT SUMMARY
Family violence, including child maltreatment and intimate partner violence, is a common and costly public
health problem with long-lasting impacts on victims. Infants experience the highest rates of child maltreatment,
and the risk of intimate partner violence has been shown to increase in the period after the birth of a child. Yet,
few family violence prevention policies target this critical period. In response to RFA-CE-25-029, this Mentored
Research Scientist Development Award (K01) Application proposes to leverage novel data linkages to study
the relationship between the implementation of a state paid family leave policy and family violence.
Specifically, the proposed study will pursue the following aims: 1) evaluate the completeness of a novel multi-
year data linkage developed for the purposes of this study using records supplied by the Colorado Department
of Labor and Employment (state paid family leave records), the Colorado Department of Public Health and
Environment (vital birth and death records), and Colorado Department of Human Services (child protection
records); 2) estimate factors that predict the use of state paid family leave, leveraging linked data at the person
level; and 3) estimate the causal effect of state paid family leave on family violence indicators during infancy
using a county-level difference-in-differences research design. Together, these aims will inform state and
federal conversations about paid family leave and assist agencies in the upstream prevention of violence. The
proposed research study addresses two research priorities of the CDC National Center for Injury
Prevention and Control—specifically, the evaluation of (1) economic supports to families to prevent
maltreatment, and (2) promising IPV prevention strategies. The PI aims to obtain formal training in causal
effects study design while expanding her expertise to encompass more forms of cross-cutting violence.
The PI will work with an interdisciplinary team of mentors who are internationally recognized experts in family
violence prevention, causal inference, and the linkage and analysis of population-based, administrative
records. The research and training proposed will provide the PI with the foundation she needs to become a
future leader in the field of violence prevention whose research findings contribute to policy development on a
national and global scale. The results of this study will support an R01 proposal to evaluate the synergistic
effects of numerous policies that support and economically strengthen families to prevent cross-cutting
violence, a CDC Injury Center research priority.

Public health relevance
PROJECT NARRATIVE The goals of the proposed Career Development Award (K01) are relevant to public health because they examine the implementation of a state paid family leave policy as a potential approach to mitigating family violence after the birth or adoption of a new child, a critical time when risk of child maltreatment and intimate partner violence is heightened. More rigorous research is needed to establish whether paid family leave might fulfill its scientific promise as an upstream approach to the prevention of violence, and to assess the policy's effect on the frequency, types, and severity of family violence. The proposed research aligns with the CDC National Center for Injury Prevention and Control's research priority to evaluate policies that provide economic support to young children and their families to prevent multiple forms of violence.